Matricellular Signaling in Engineered Tracheal Transplantation

ABSTRACT Tracheal deficiency of any cause represents a potentially fatal process. Presently there are no available substitutes for the trachea and it remains one of the few vital organs that can neither be reconstructed from other tissues nor effectively transplanted. Researchers have begun to explore the possibility of organ replacements from scaffolds (decellularized trachea) that can then be transplanted to a patient. However, these first cases have been troubled by a range of serious problems all ultimately linked to a lack of healing. We believe that the lack of healing could be related to the secreted protein thrombospondin-1 (TSP1) an identified anti-angiogenic agent that binds to matrix and to cell receptors and is induced by healing tracheal cells. We found that limiting TSP1 signaling through agents that prevent its binding to a specific cell membrane receptor, CD47, which is expressed on tracheal epithelial, cartilage and vascular cells, increases cell restoration of decellularized tracheal scaffolds and tissue healing or transplanted decellularized tracheal scaffolds. We have developed several technologies that target and suppress the maladaptive TSP1-CD47 signal including a CD47 specific antibody and a CD47 specific peptide. In tracheal cells we will test these technologies to increase cellular restoration of decellularized 2- and 3-D tracheal scaffolds. Bench top results will inform experiments to test these novel engineered tracheal transplants to heal tracheal loss in rodent and canine models of orthotopic tracheal transplantation. As humanized versions of CD47 targeting technologies are in development and, in the case of CD47 antibodies, in clinical trials results from this proposal will support accelerated translation into the clinic.

Public health relevance
NARRATIVE The trachea is vital organ that, consequent to its unique and complex anatomic structure, has limited options for repair. Individuals who experience substantial tracheal loss or compromise endure profound lifelong complications and loss of quality of life. Unlike other vital organs, transplantation of donor tracheas, although technically possible, is also not a valid solution to tracheal loss. In this proposal tissue engineering employing decellularized tracheal scaffolds in combination with methods to enhance tissue healing will be examined to induce regeneration of functional tracheal transplants.